PHARMACOLOGY CONSULTING SERVICES

This contract is to support pharmacology-related consulting services for the Contraception Research Branch (CRB) of the Eunice Kennedy Shriver National Institute of Child Health and Human Development.